Applying motor learning principles to dysphagia rehabilitation

DESCRIPTION (provided by applicant): The overall goal is to exploit motor learning principles in a novel way to enhance dysphagia rehabilitation in patients with dysphagia due to stroke. Dysphagia is swallowing impairment that can lead to serious illness or death due to ingested material entering the trachea (aspiration). This study addresses the mission of the agency, because it fosters development of scientific knowledge needed to enhance the health, productivity, independence, and quality-of-life of people with physical disabilities. Specifically, this study will determine whether lasting behavioral modifications after swallowing training occur with motor learning principles versus standard care. Motor learning principles emphasize continual kinematic assessment through biofeedback during training. However, continual kinematic assessment is rare in standard dysphagia care because swallowing kinematics require instrumentation such as videofluoroscopy (VF) to be seen. Since VF involves radiation exposure and higher costs, submental electromyography (sEMG) is widely used as biofeedback, although it does not image swallowing kinematics or confirm that a therapeutic movement is being trained. In this initial phase 1 clinical trial, we will compare three forms of biofeedback on training a swallowing maneuver called volitional laryngeal vestibule closure (vLVC), which emphasizes swallowing airway protection. VF biofeedback training will provide kinematic information about vLVC performance, incorporating motor learning principles. sEMG biofeedback training will provide non-kinematic information about vLVC performance and, thus, does not incorporate motor learning principles. We will also investigate a mixed biofeedback training, which involves VF biofeedback early on to establish the target kinematics of the vLVC maneuver, then reinforces what was learned with sEMG. Mixed biofeedback training is being examined because it is more clinically feasible than VF biofeedback training, while still incorporating motor learning principles during part of the vLVC training. We hypothesize that VF training will reduce swallowing impairment more than mixed training, but mixed training will reduce swallowing impairment more than sEMG training. Additionally, this study will investigate whether adjuvant techniques known to augment motor training (non-invasive neural stimulation and explicit reward tested independently), will augment outcomes of each of the proposed trainings. Our innovative experimental design is significant because it investigates motor learning principles within an ideal training (VF biofeedback) as well as within a clinically feasibe option (mixed biofeedback) to differentiate them from standard dysphagia training (sEMG), which has reported little to no improvements after intense motor training. Outcomes from our proposal may change the paradigm for treating swallowing and other internal functions such as speech and voice disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our overall goal is to exploit motor learning principles and adjuvant techniques in a novel way to enhance dysphagia rehabilitation. The proposed study will investigate the effects three forms of biofeedback on training and determine whether adjuvant therapeutic techniques such as non- invasive neural stimulation and reward augment training outcomes. The findings from this proposal have the potential to change the paradigm of dysphagia rehabilitation among multiple disciplines.